Cell type specific analysis of Src kinase-NMDA receptor complexes in schizophrenia

PROJECT SUMMARY
Recent evidence from genetics, neuroimaging and postmortem studies collectively points to synaptic
pathways as a locus of pathophysiologic mechanisms of schizophrenia. In particular, dysregulation of
glutamatergic signaling has been among the most highly implicated for synaptic pathology of the illness.
Previously, we proposed Src kinase (Src) as one of the points of convergence for multitudes of molecular
alterations in glutamatergic complexes in the postsynaptic density (PSD) in schizophrenia. Our scientific
premise is that Src kinase and its aberrant associations with its binding partners form a
pathophysiologic subnetwork underlying altered PSD/glutamatergic signaling and thus represent
potential therapeutic targets. This premise is predicated on a series of observations we have made including
1) NMDA receptor (NMDAR) hypoactivity in the postmortem dorsolateral prefrontal cortex (DLPFC) of
schizophrenia is associated with decreased tyrosine phosphorylation of GluN2 in NMDAR complexes. 2)
NMDAR hypoactivity is driven by hypoactivity of Src kinase, which results from aberrant protein-protein
interaction (PPI) of Src with its signaling partners. 3) Molecular and behavioral phenotypes of NMDAR
hypoactivity can be rescued by modifying altered Src-PSD-95 association using a peptide, called Src activating
PSD-95 inhibiting peptide (SAPIP). Synaptic alterations lead to disrupted circuit activity via aberrant
interactions between pyramidal neurons (PNs) and interneurons (INs). The goal of this project is to determine
Src mediated NMDAR signaling alterations distinctly in PNs vs. INs and their differential responses to
potential therapeutic interventions. Previous postmortem assessments of glutamatergic signaling, by our lab
and others, were conducted in bulk tissues, not offering a cell type specific resolution. To address this, we will
employ two recently devised methods. The first is sequential immunoprecipitation (IP), in which the receptor
complexes in each cell type are captured first by GluN1, common to both cell types, followed by another round
of IP using a bait protein that is expressed exclusively in the cell type of interest and yet integral to the protein
complexes of interest. The second is multi-channel confocal microscopic analysis of synaptosomes combined
with cell type specific labeling and the proximity ligation assay (PLA). Employing these complementary
methods, we will examine postmortem DLPFC and test if Src kinase activity and their downstream signaling
are altered in PNs vs. INs in schizophrenia (Aim 1). In addition, we will examine how Src-NMDAR signaling is
modulated by SAPIP and other agents in each cell type (Aim 2). The results of this study will be the first to
address signaling and PPIs in postmortem brains in specific cell types and will inform the distinct constellation
of glutamatergic receptor complexes and signaling in pyramidal vs. interneurons.

Public health relevance
PROJECT NARRATIVE Schizophrenia is associated with disrupted activity of brain circuitry, precipitated by aberrant synaptic interactions between pyramidal and interneurons. Previously, we reported that Src kinase signaling, the hub of N-methyl-d- aspartate (NMDA) receptor pathway in the postsynaptic neurons, is reduced in schizophrenia, resulting from convergence of multitudes of molecular alterations schizophrenia. This project is designed to investigate how Src ad NMDAR signaling is altered distinctly in pyramidal neurons vs. interneurons.